Social Isolation and Metabolic Homeostasis: Investigating the Role of Oxytocin in Modulating Hypothalamic Glucose Sensing

PROJECT SUMMARY/ABSTRACT
Perceived loneliness is an independent risk factor for both diabetes and dementia. Older adult populations are
a high-risk group for the metabolic and cognitive consequences of social isolation due to frailty, loss of mobility
and lack of affordable transportation. However, the neural mechanism underlying the relationship between social
connection, glucose homeostasis, and cognitive health is poorly understood. To address this gap, my F99/K00
proposal builds on preclinical and clinical evidence demonstrating that social isolation negatively impacts glucose
homeostasis. Glucose regulation is critical in the progression of both diabetes and dementia. Oxytocin is a
neurohormone which modulates social behavior and energy balance. The oxytocin receptor (OTR) is highly
expressed in the ventromedial hypothalamus (VMH), a brain area critical to glucose homeostasis. VMH glucose
sensing neurons respond to fluctuations in extracellular glucose to regulate peripheral glucose homeostasis.
However, the role of oxytocin in modulating VMH glucose sensing and the extent to which social isolation disrupts
VMH glucose sensing has never been investigated. Our preliminary data demonstrate that:1) single-housed mice
are hyperglycemic compared to co-housed mice; 2) VMH OTR neurons are inhibited by glucose; 3) VMH OTR
neurons co-express neuronal nitric oxide synthase (nNOS), a marker for glucose-inhibited (GI) neurons.
Together, this evidence supports our central hypothesis that oxytocin modulates VMH glucose sensing
neurons, and that social isolation amplifies this modulation leading to a hyperglycemic phenotype.
AIM 1 F99 Phase: I will investigate the mechanism by which social isolation induces hyperglycemia. I will
perform whole-cell patch clamp electrophysiology in brain slices to determine whether oxytocin modulates GI
neurons. I will use in vivo fiber photometry calcium recordings to determine if VMH-OTR activity increases during
induced hypoglycemia. I will use CRISPR/Cas9 to selectively knock down the VMH OTR receptor in co-housed
mice and determine glycemic differences compared to controls. These F99 experiments will contribute
mechanistic insights regarding the role of oxytocin in social isolation-induced glucose dysregulation. My training
plan will provide the conceptual and technical neuroscience foundation necessary for the K00 phase of my career
development plan.
AIM 2 K00 Phase: I will determine if social contexts affect cognitive aging via oxytocin control of
glycemia AIM 2A will use an aging rodent model to determine how different patterns of endogenous oxytocin
release affect glucose homeostasis and memory performance. These experiments will allow me to build on my
F99 skillset and gain expertise in optogenetics, social behaviors, and cognitive testing assays. AIM 2B will use
secondary analysis methods to model human longitudinal data and identify the specific social relationships that
mediate the link between loneliness, diabetes, and cognitive function in diverse patient sub-populations

Public health relevance
PROJECT NARRATIVE Social isolation is an independent risk factor for diabetes and dementia. However, the neural mechanism underlying the relationship between social connection, glucose homeostasis, and dementia is poorly understood. This combined F99/K00 research strategy bears public health significance and will contribute neurobiological insight underlying the relationship between loneliness, glucose regulation and cognitive function.